Investigating the Impacts of Pharmacological Slow Wave Sleep Enhancement on Cognition and Memory Traces in an Alzheimers Disease Model

PROJECT SUMMARY / ABSTRACT
Alzheimer’s disease (AD), a debilitating neurodegenerative condition projected to affect over 150 million people
by 2050, is associated with major disruptions in sleep. Sleep is an essential, ubiquitous process in all animals
and is now recognized as a significant modulator of AD pathology. Recent literature indicate there is a particularly
strong bidirectional relationship between loss of slow-wave sleep (SWS), the deepest sleep stage, and severity
of AD. Additionally, studies enhancing slow-wave activity (SWA) in AD and other mouse models of
neurodegeneration show improved pathology, suggesting this intervention has promising therapeutic potential.
However, there is a gap in knowledge of whether this SWA enhancement is capable of improving memory
deficits in AD and/or normalize sleep-wake disturbances, which are emerging biomarkers of AD. Here, I will test
the hypothesis that pharmacological SWA enhancement in the APP/PS1 mouse of model of AD normalizes
sleep-wake rhythms, decreases plaque burden, and improves memory performance by altering neural
ensembles underlying memory. I will use a comparative approach to test the efficacy of two compounds,
gaboxadol, a selective GABAA agonist, and trazadone, an FDA approved atypical antidepressant, that have
been well-characterized for their SWA-enhancing effects. In Aim 1a, I will use in vivo microdialysis and
PiezoSleep recordings to investigate if administration of gaboxadol or trazadone to APP/PS1 mice normalizes
characteristic sleep-wake disruptions in activity and interstitial A rhythms. In Aim 1b, I will use
electroencephalography (EEG) recordings to investigate if chronic administration of either drug to APP/PS1 mice
improves associated disruptions to sleep architecture. I will additionally assess for decreases in plaque burden
after both of these experiments. In Aim 2, I will investigate if SWA enhancement with either drug is able to
improve memory performance, and if this is mediated by systems-level alterations in memory traces, the
proposed biological substrates underlying memory encoding, storage, and retrieval. I will use a custom brain
wide mapping pipeline to investigate how memory traces are altered in the hippocampus (HPC), and additional
relevant regions such as the amygdala (AMY), nucleus reuniens (NE), and retrosplenial cortex (RSC).
Successful completion of this project will critically inform our understanding of the therapeutic potential of
pharmacological SWA enhancement as a treatment strategy in AD. It will further elucidate the regional and
network-level changes that may mediate its effects. The research and scientific expertise additionally developed
through this Kirschstein-NRSA F30 Fellowship Award will support my long-term goal of becoming an
independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a debilitating and irreversible neurodegenerative disease associated with major disruptions to sleep, an essential and ubiquitous process in all animals. Recent works reveal there is a strong bidirectional relationship between loss of slow-wave sleep (SWS), the deepest sleep stage, and the pathological and cognitive features of AD. Here, I will investigate whether chronic pharmacological slow-wave activity (SWA) enhancement can improve pathology and disturbances to sleep-wake rhythms and sleep architecture (Aim 1), as well as rescue behavioral and biological measures of memory deficits (Aim 2) in a mouse model of AD.